Administrative Core

PROJECT SUMMARY/ABSTRACT
The Administrative Core provides innovative scientific and organizational leadership in the coordination, management, and oversight of Harvard University (HU) CFAR activities across its participating institutions. The Administrative Core provides a structure to support the programmatic and fiscal needs of the CFAR in facilitating innovative, multidisciplinary HIV research and training the next generation of HIV investigators. The Administrative Core also oversees the CFAR strategic planning process to ensure that it continues to serve the needs of the Harvard HIV investigator community in advancing transformative research and providing leadership in global efforts to prevent and treat HIV.

Public health relevance
The Administrative Core aims to: 1. Provide programmatic, administrative and fiscal support to CFAR Cores, Scientific Working Groups and Scientific Programs, including their research, educational and training initiatives. 2. Implement new strategic initiatives, including programmatic and administrative support for CFAR Steering Committees working on high-priority areas. 3. Utilize multiple communications strategies to inform the HU CFAR community. 4. Oversee and direct strategic planning, policies and procedures